Develop pan-specific antibody against mutant glycyl-tRNA synthetase for treating CMT2D

Abstract
Charcot-Marie-Tooth (CMT) disease type 2D is caused by dominant mutations in GARS, encoding glycyl-tRNA
synthetase (GlyRS). CMT is a clinically and genetically heterogeneous collection of disorders in which peripheral
motor and sensory axons degenerate. The diseases specifically affect the peripheral nervous system and are
characterized by progressive motor neuron degeneration, muscle atrophy, and sensory loss. None of the CMT
disease subtypes have a targeted treatment, thus CMT remains an unmet medical need. The genetic
heterogeneity makes it unlikely that a single therapy will be effective for all forms of CMT. Although gene
therapies have emerged strongly for monogenic diseases such as CMT, the large number of different mutations
involved, and the small number of patients affected by each mutation render classic gene therapy onerous for
CMT2D. Identifying a causal treatment strategy applicable to different mutations in GARS would therefore be
the most attractive therapeutic approach for CMT2D. Also, being able to directly engage with the GlyRS protein
itself is key to CMT2D remediation. Our previous work has established that a major source of the toxicity of the
CMT-causing mutant GlyRS is originated from the extracellular space, where mutant proteins aberrantly interact
with Neuropilin 1 (Nrp1) receptor and antagonize a signaling pathway important for motor neuron maintenance.
We designed a novel strategy based on our structural insight of the GlyRS mutants. We found that different
CMT2D mutations caused a shared conformational change in GlyRS that exposes new protein surfaces at the
dimer interface to solution. By using two different peptides from the dimer interface of GlyRS as antigens for
immunization, we have successfully obtained two monoclonal antibodies (mAbs) (one for each peptide) from
mouse hybridomas that can block the pathological Nrp1 interaction and exhibit promising pan-mutant selectivity.
These two mAb candidates will be characterized for their biophysical properties, and used for conducting
pharmacodynamic, pharmacokinetic, and in vivo efficacy studies in a mouse model of the human disease to
evaluate whether they have sufficient biological activity to warrant further development to treat CMT2D.

Public health relevance
Narrative This application is in response to FOA PAR-18-761 to conduct pharmacodynamic, pharmacokinetic, and in vivo efficacy studies to evaluate two novel monoclonal antibodies that have been designed to recognize a specific region of glycyl-tRNA synthetase (GlyRS) and to demonstrate that these antibodies have sufficient biological activity to warrant further development to treat Charcot-Marie-Tooth disease type 2D (CMT2D).